Spatiotemporal control of transcutaneous spinal cord stimulation for motor function in SCI

PROJECT SUMMARY/ABSTRACT
Spinal cord injury (SCI) is a life-altering event that leads to long-lasting motor impairment. Currently, there is no
cure for paralysis. Transcutaneous spinal cord stimulation (tSCS) combined with exercise training can restore
posture control, voluntary walking, and arm/hand function in people with SCI. However, its low selectivity in
activating specific muscles compared to invasive approaches limits the rehabilitation exercises that can be
practiced and help with recovery. This project will generate evidence-based knowledge of the neural
mechanisms underlying spatial, frequency, and amplitude control of tSCS in generating different types of leg
movements. Participants with SCI will perform leg movements using different stimulation parameter
configurations in non-invasive tSCS. We will quantify changes in muscle recruitment, torque generation, and
pain enabled by the different stimulation parameters. A clear understanding of the mechanisms by which these
different parameters in non-invasive tSCS can be used to selectively target different muscle groups will promote
the development of personalized therapies that directly target only those muscles that need assistance while
respecting individuals' residual motor function.

Public health relevance
PROJECT NARRATIVE Spinal cord injury leads to long-lasting impairment, and currently, there is no cure for paralysis. Although transcutaneous spinal cord stimulation has shown promising results in recovering lost movements, its poor selectivity in muscle recruitment compared to invasive approaches limits the type of rehabilitation exercises that can be practiced. This project studies how spatial, frequency, and amplitude control of stimulation can be used to selectively target different neural pathways and muscle groups.